Epidemiology and Etiology of Hospitalized Pneumonia in Children

PROJECT SUMMARY/ABSTRACT Pneumonia in children is a major cause of morbidity and the leading cause of death in children younger than 5 years of age worldwide. Among children in the United States, pneumonia and influenza are the eighth leading causes of death. Although the burden of pneumonia in children is well appreciated, recent data on the incidence and etiology of pneumonia in children are few. Thus far, determining the true etiology of pneumonia is complicated due to 1) the large number of bacterial and viral agents that may cause pneumonia; 2) the frequency of viral and bacterial co-infections; 3) the limited availability of deep respiratory specimens from children; 4) the limitations of current laboratory technology and 5) antibiotic therapy initiated before microbiological evaluation. These limitations result in empirical clinical management of children with pneumonia. The optimum management of pediatric pneumonia is dependent on understanding the epidemiology of the pathogens that cause pneumonia by age and geographic region. The University of Utah, in collaboration with the Associated and Regional University Pathologists Laboratories and Research Enterprise, as well as Idaho Technology, Inc., is uniquely suited to address this problem. As part of a multicenter research study directed by the CDC, we are conducting a prospective study to identify viral and bacterial pathogens which cause community-acquired pneumonia and complicated bronchiolitis in hospitalized children. To determine the incidence and etiology of pediatric hospitalized pneumonia and to further understand the complications associated with influenza, we propose the following Specific Aims: Specific Aim 1: Identify all children in Salt Lake County diagnosed and hospitalized for clinically diagnosed and radiologically-confirmed CAP. Specific Aim 2: Determine the population-based incidence, etiology, and outcomes of pediatric influenza-associated pneumonia in Salt Lake County, including primary viral pneumonia, viral and bacterial co-infection, and post-influenza bacterial pneumonia. Specific Aim 3: Document the bacterial and viral etiology of pediatric pneumonia due to established and emerging pathogens using molecular analysis and high-order multiplex testing. Improve the ability to identify the etiology of presumed bacterial infection using molecular analysis of pleural fluid and blood. Quantify and compare respiratory viral loads in children hospitalized with pneumonia. a. b.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Our study, Epidemiology and Etiology of Hospitalized Pneumonia in Children, supports and addresses the National Center for Immunization and Respiratory Diseases (NCIRD) of CDC objectives of "Healthy People 2020" to prevent disease, disability, and death from infectious diseases, including vaccine-preventable diseases to protect Americans from infectious diseases. This study, the largest of its kind, will lead to improved understanding of the spectrum of viruses and bacteria responsible for pneumonia, which will aid clinicians in making appropriate treatment decisions, including antimicrobials. The data obtained from the proposed studies will be vital for the evidence-based management of pneumonia in children and understanding the frequency and etiology of bacterial infections following influenza will aid in future pandemic planning. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Worldwide, pneumonia is the leading cause of death in children younger than 5 years and is an important cause of pediatric death in the US.1,2 Unfortunately, recent data on the incidence and etiology of pediatric community acquired pneumonia (CAP) are few. Studies undertaken in the1980s, 3,4 before licensure of Haemophilus influenzae type b (Hib) and Streptococcus pneumoniae conjugate vaccines (PCV7), reported an incidence of 36-40 episodes/1000 children/ year in those younger than 5 years and 11-16 episodes/1000 in those 5 to 14 years 3,5 Introduction of Hib in 1990 and PCV7 in 2000 resulted in major changes in the epidemiology of pediatric CAP. By 2006, there was a 54% decline in pneumonia hospitalization in children younger than 2 years compared with 1999, but no change in older children.6,7 New pathogens also emerged, including methicillin-resistant Staphylococcus aureus (MRSA) and viruses such as human metapneumovirus,8,9 and non-SARS coronaviruses.10 In 2009 novel influenza virus, A California 2009 H1N1 resulted in a pandemic associated with increased hospitalization for parapneumonic empyema in children and identification of obesity as a risk factor for complications following influenza infection.11-13 Determining the etiology of pneumonia is challenging. There are many bacterial and viral agents that produce similar features and viral and bacterial co-infections are common. Diagnostic testing is limited by the availability of both specimens from children and molecular technology. Optimum management of pediatric CAP is dependent upon understanding the epidemiology of the pathogens that cause CAP by age, season, and geographic region. Bacterial pneumonia and its complications were a leading cause of death during past and recent influenza pandemics.14-17 Greater epidemiologic knowledge of pediatric CAP will improve clinical care, patient outcomes, and national preparedness. University of Utah in conjunction with two Intermountain Health Care (IHC) hospitals, Primary Children's Medical Center (PCMC) and Riverton Hospital (RH) are uniquely positioned to evaluate the changing epidemiology of pneumonia in children. Together, over 90% of hospitalizations of children in Salt Lake County occur at these hospitals. The Utah Department of Health (UDOH) also collects data on all hospital discharges in children and adults in Utah, including all pneumonia admissions. The combination of these resources allows accurate capture of all pneumonia admissions by age group, county and diagnosis. We are also in close proximity and active collaboration with state-of-the art molecular laboratories, including the Associated and Regional University Pathologists (ARUP) Laboratories and Research Enterprise, as well as Idaho Technology, Inc. (ITI), an innovative biotechnology company developing real-time diagnostics for respiratory disease. The goal of this proposal is to determine population-based incidence, etiology and outcomes of CAP in hospitalized children in Salt Lake County, Utah, using state of the art diagnostic methods. hypothesize that respiratory viruses, particularly influenza are commonly associated with bacterial CAP. We We will use PCR and serology to detect respiratory viruses and PCR to identify bacterial infection in blood and pleural fluid to elucidate the interactions between respiratory viruses and bacteria in CAP. Specific Aim 1: Identify all children in Salt Lake County diagnosed and hospitalized for clinically diagnosed and radiologically-confirmed CAP. Specific Aim 2: Determine the population-based incidence, etiology, and outcomes of pediatric influenza- associated pneumonia in Salt Lake County, including primary viral pneumonia, viral and bacterial co-infection, and post-influenza bacterial pneumonia. Specific Aim 3: Document the bacterial and viral etiology of pediatric pneumonia due to established and emerging pathogens using molecular analysis and high-order multiplex testing. a. Improve the ability to identify the etiology of presumed bacterial infection using molecular analysis of pleural fluid and blood. b. Quantify and compare respiratory viral loads in children hospitalized with pneumonia. The successful achievement of these Specific Aims will enable us to determine the incidence and etiology pediatric hospitalized pneumonia, and to further understand the complications associated with influenza. The sharing of our data with the Centers for Disease Control and Prevention will allow us, in collaboration with the other awardees, to expand our knowledge of the incidence and etiology hospitalized pneumonia in the US and to improve treatment.